Immunology Team Contributions to the PSIIM

The PSIIM Program in Systems Immunology and Infectious Disease Modeling represents a new multidisciplinary research initiative focused on the immune system, with an emphasis on quantitative, computer-based, microscopic and macroscopic modeling of immune functions, integration of these modeling efforts with data sets derived from global analyses of cell components, and the development and application of advanced imaging methods to the analysis of immune responses in vivo in models systems, and ultimately, man. The program is designed to deal with the existing lack of any large-scale effort to understand the engineering of the immune system from the biochemical through the organismal levels and to generate predictive models based on such understanding. The overall goal of the PSIIM will be the development of a new level of integrated understanding of how the immune system functions and how it interacts with pathogens. The primary imperative would be accumulation of the specific information necessary to devise robust quantitative, predictive models of immune behavior in various circumstances, including exposure to infectious agents, following vaccine administration, or in autoimmune diseases. A key effort will be the implementation of the type of measurement rigor needed for effective modeling at all levels of immune organization, from the biochemical to the whole animal. During the past 2 years, the Immunology Team has undertaken as a major project the a top-down analysis of the immune and non-immune tissue response of mice to various strains of influenza virus. Highly standardized preparations of both mildly pathogenic (Tx91) and highly pathogenic (PR8) viruses have been used at varying infectious doses in a single inbred strain of mouse and several hundred highly qualified microarray transcriptional analyses have been conducted with RNA isolated from infected lung tissues of these mice at varying time points post-inoculation. Initial findings suggested marked differences in the types of immune cells and immune factors present at the site of infection at early time points in mice given the Tx91 vs. the PR8 viruses, with some of the data pointing to possible explanations for the marked differences in pathogenicity of the two infectious agents in terms of distinct myeloid cell responses to the viruses. Last year we developed methods for 9+ color flow cytometric separation of hematopoietic cell subsets (lymphoid and myeloid) and non-hematopoietic cells from infected lungs, validated the separation methods as not contributing to substantial changes in RNA patterns, and completing acquisition of microarray data on these purified subpopulations to increase the resolution of the analysis. In addition, immunohistochemical studies of viral protein expression have been completed on infected tissues, as have flow cytometric studies of the cells present in infected lungs, to correlate with the microarray data. These data complement the array data in pointing to a special role for myeloid cells in the difference pathogenicity of the two primary strains of virus being studied, and these implications are consistent with data obtained with data obtained using a third strain of virus that differs in its HN type but shares core components with the lethal virus and that has an intermediate phenotype. A variety of informatic tools have been employed to organize and analyze the emerging data sets, especially a k-means clustering algorithm that allows study of the RNA response in terms of co-regulated gene sets with linked function (modules). Work is underway on generation of viral re-assortments to map the genomic regions involved in the marked pathogenicity difference between PR8 and Tx91, which will enable us to relate viral genetic variation to differences in host response and to begin construction of Bayesian models of the network of interactions involved in each infectious process.